Annual Meeting of the Association for Chemoreception Sciences (AChemS)

Project Summary
The objective of this conference grant request is to continue to provide support for aspects of the annual
meeting of the Nation’s major chemical senses research society, the Association for Chemoreception Sciences
(AChemS) for the next 5 year period.
The specific objectives are:
Aim 1 - Bring outside scientists to the meeting to catalyze cutting edge interdisciplinary and
translational research
Aim 2 - Accelerate the increase in participation of underrepresented individuals, veterans and persons with
disabilities in the chemical senses

Public health relevance
Project Narrative The chemical senses play a role in socially relevant major diseases associated with the regulation of food intake - including diabetes, hypertension, obesity, and colon cancer – in addition to their better known association with aging. This meeting catalyzes chemical senses research for human health.